Mayo Clinic Building Interdisciplinary Research Careers in Women’s Health

ABSTRACT
This is a supplement application to the Mayo Clinic BIRCWH program, which has been funded for three cycles
since 2010. During this time, we have demonstrated progress toward our long-term goal of increasing the
science workforce of interdisciplinary teams translating scientific discoveries into clinical practice to improve
women’s health. With this supplement, we will be able to increase the participation of an underrepresented
minority scholar in our program. Evidence of success of our program is provided by the eighteen scholars
trained in the BIRCWH program who enhanced the interdisciplinary research in women’s health at Mayo Clinic.
BIRCWH scholars received 61 grants as Principal Investigators with a return of investment of $2.91 per NIH
dollar as Principal Investigators and $30.2 per NIH dollar as Principal Investigators or Co-Investigators. Our
short-term goal in this cycle is to provide training to investigators who can assume leadership roles in
interdisciplinary research teams in women’s health. In order to achieve these goals, our program plan is
structured around three aims that align with the three pillars of the BIRCWH program: interdisciplinary
research, mentoring, and career development. First, we aim to recruit a diverse group of early-stage
investigators with an outstanding potential to lead interdisciplinary research teams in women’s health. Our
second aim is to provide both structured and tailored educational experiences based on career development
needs that include didactic programs and a mentored research experience in an interdisciplinary environment.
And finally, we aim to partner with other BIRCWH programs, career development programs within Mayo Clinic,
and nationally, to enhance training in women’s health research and foster a community of scholars. A strong
community of fellow scholars and established investigators in women’s health research provides the
networking opportunities and supports collaborations essential for sustaining and developing new
interdisciplinary research programs. The rich environment of other career development programs at Mayo
Clinic such as the Mayo Clinic Center for Translational and Clinical Science (CCaTS) and the Specialized
Centers of Research Excellence (SCORE) on Sex Differences programs, training in incorporating sex as a
biological variable in research, and our collaborations with the BIRCWH programs at other institutions provide
outstanding networking opportunities for our scholars. The historically underrepresented minority scholar
supported by this supplement will have the opportunity to train in the mature and highly successful Mayo Clinic
BIRCWH Program.

Public health relevance
NARRATIVE Building Interdisciplinary Research Careers in Women’s Health (BIRCWH) Scholars Program is developed based on the need for a science workforce with skills necessary to work in interdisciplinary teams and translate scientific discoveries into clinical practice to improve women’s health. Mayo Clinic BIRCWH program has been fulfilling this need by training Scholars who enhance the interdisciplinary research in women’s health at the Mayo Clinic and across the Nation. This supplement will allow us to provide training for an underrepresented minority scholar in the mature and highly successful Mayo Clinic BIRCWH Program.